Dissecting the Etiology of The Lewy Body Dementias

PROJECT SUMMARY
Lewy Body dementia (LBD) is the second most common neurodegenerative disorder, afflicting 1 million people
in the US. It is fatal, and its incidence is increasing as populations age. LBD includes dementia with Lewy bodies
(DLB) and Parkinson disease (PD) with dementia (PDD), but it is not clear if DLB and PDD are distinct diseases
with different underlying mechanisms or clinical syndromes on a single mechanistic spectrum. Their relationship
to Alzheimer’s disease (AD) is also unclear. Answering these questions is important for patient care, as DLB
patients may respond differently to drugs than PDD or PD patients, and the diseases may progress at different
rates. We propose to investigate the molecular basis of DLB and PDD as a way to identify disease-specific
therapeutic targets and biomarkers that will lead to effective treatments. We postulate that in each disease,
alpha-synuclein (aSYN), a major component of Lewy bodies, may adopt different conformations or covalent
modifications, and that these different forms of aSYN determine the neuron subtypes that degenerate and the
clinical syndrome that ensues. Consistent with this hypothesis, our genetic analysis of DLB patients has shown
that different aSYN gene (SNCA) variants are associated with DLB compared to PD. We also discovered that a
unique family of antibodies against different regions and post-translational modifications of aSYN reveal different
pathologies in the DLB brain. Our central hypothesis is that DLB and PDD are distinct diseases with distinct
underlying mechanisms. To test this hypothesis, we will first analyse patient brain samples with digital pathology,
combining new artificial intelligence (AI)-based approaches with classical hallmark pathology and some new
indicators of pathology, including the antibodies specific to different forms of aSYN. We will determine if we can
train deep learning (DL) algorithms to accurately diagnose DLB versus PDD and reveal the key features that
form the basis for that diagnosis. Second, we will test if DLB and PDD can be distinguished genetically. We
reported the first genome-wide association study (GWAS) for DLB and will now use a similar approach in PDD
compare these findings to available AD and PD genetic data. To this end, we will also analyze PDD and DLB
patients using GWA with well-defined AI-quantified pathological endophenotypes for the first time This work will
uncover genetic determinants that predict clinical symptoms of DLB and PDD patients and the neuropathology
and provide novel stratification schemes for these conditions. Third, we will use snRNA-seq and spatial
transcriptomics on brain tissue to determine if we can distinguish DLB and PDD patients based on their
respective transcriptomic signatures. We will further validate and integrate these results by testing if the genes
differentially expressed in DLB and PDD patients can form the basis for new neuropathology labels and AI
algorithms that distinguish DLB and PDD brains. Our studies will clarify the neuropathological, molecular and
genetic differences and similarities between PDD and DLB, and identify the genetic determinants of LBD, paving
the way for the development of targeted diagnostics and therapeutics.

Public health relevance
PROJECT NARRATIVE We propose studies to determine whether dementia with Lewy bodies (DLB) and Parkinson disease with dementia (PDD) are neuropathologically, molecularly and genetically distinct neurodegenerative diseases using novel probes that distinguish different species of alpha-synuclein, a major component of Lewy bodies (LBs), and new artificial intelligence (AI) approaches that may reveal distinct features of the two conditions in post-mortem brains. We reported the first DLB genome-wide association study and will now use a similar approach to identify genetic determinants that predict the neuropathology and/or clinical symptoms of PDD patients and develop novel stratification schemes for DLB and PDD patients. We will use snRNA-seq and spatial transcriptomics on brain tissue to determine if transcriptomic signatures can distinguish DLB and PDD patients and be used to design new neuropathology labels and AI algorithms aimed at distinguishing DLB from PDD brains.